ARID1 proteins orchestrate cranial neural crest differentiation

Project Summary (Abstract)
Cranial neural crest cells (CNCCs) are a unique, multipotent, migratory population that give rise to both
ectodermal/non-ectomesenchymal (neurons, glia) and mesodermal/ectomesenchymal (bone,
cartilage) derivatives. The cellular and molecular mechanisms that allow for proper craniofacial
development, including establishing multipotency, epithelial to mesenchymal transformation (EMT) and
migration; however, remain controversial and heavily focus on transcription factor expression. BAF is
one of the major protein complexes regulating chromatin accessibility. AT-rich interactive domain-
containing proteins 1A and 1B (ARID1A, ARID1B) are the largest, mutually exclusive, subunits of BAF
and mutations in these subunits result in Coffin-Siris Syndrome (CSS), a disorder characterized by
craniofacial phenotypes. Our previous work revealed a dynamic requirement for ARID1A/B during
CNCC development in which ARID1A was required for maintenance of pluripotency and then as iPSCs
differentiated into neurosphere intermediates, was decommissioned, and replaced by ARID1B to initiate
commitment to the neuroectodermal lineage via the repression of thousands of pluripotency enhancers
and genes. Upon differentiation of neurospheres into CNCCs, ARID1B was downregulated and ARID1A
was reactivated. We hypothesize that the return of ARID1A in CNCCs is essential for
multipotency, EMT, and migration of CNCCs, and that as CNCCs differentiate, ARID1B is
reactivated to ensure lineage commitment. Interestingly, there is potential integration of chromatin
remodeling activity with key developmental signaling pathways whereby the induction of CNCCs is a
Wnt-dependent process and phenotypes associated with loss of ARID1A/B are similar to mutations
linked to the Hedgehog (Hh) pathway. Further, our preliminary data identified an enrichment for
TCF/LEF and ZIC2/3 binding sites in ARID1A bound regions and proteomic studies highlighted physical
interactions with the transcription factor, Gli3. Gli3 acts as a bimodal regulator (e.g., can function as
both an activator and repressor) of the Hh signaling pathway and has not previously been ascribed
chromatin remodeling capability. Thus, we hypothesize a novel mechanism of Gli regulation which
utilizes Arid1 subunits. Herein, we propose three distinct Aims to test our hypotheses. Aim 1: will test
if ARID1A regulates multipotency, induction, EMT, and migration of CNCCs, by cooperating with
pluripotency factors (OCT4, SOX2, NANOG), Wnt signaling transcription factors (LEF1/TCF), and
ZIC2. Aim 2: will determine if ARID1A/ARID1B mediated mechanisms (chromatin remodeling and/or
RNA Pol II pausing) are necessary for CNCC differentiation. Aim 3: will determine if Gli3 cooperates
with ARID1A and ARID1B to drive transcriptional activation and repression, respectively. The proposed
studies will shed new light on cellular and molecular mechanisms required for CNCC induction,
multipotency, and differentiation. Furthermore, they will be the first studies to reveal mechanisms by
which the BAF complex contributes to transduction of signaling pathways (e.g., Hh and Wnt) essential
for craniofacial development.

Public health relevance
Project Narrative: Mutations in ARID1A and ARID1B are associated with Coffin-Siris Syndrome, a congenital disease characterized by craniofacial malformations. We will use patient specific cell lines and animal models to study the role both genes play in coordinating the earliest stages of craniofacial development, namely the development of cranial neural crest cells into skeletal derivatives. These studies have the potential to identify novel molecular mechanisms and interactions with other key regulators essential for craniofacial and neural crest development and differentiation.